Natural History of Lung Cancer Diagnosed Within and Across Diverse Health Systems Implementing Lung Cancer Screening

Project Summary/Abstract
The goal of this application is to support Nikki Carroll, MS, as a Research Specialist and
Biostatistician at Kaiser Permanente Colorado Institute for Health Research. She supports the
Cancer and Genomics Research Core under the direction of Debra Ritzwoller, PhD. The core of
Ms. Carroll’s productive and successful career as a Research Specialist and Biostatistician is in
cancer related treatment patterns and outcomes. This Research Specialist award would allow 5
years of funding to maintain protected time for Ms. Carroll to work exclusively on supporting and
leading cancer research aimed at generating real-world evidence on cancer care that occurs
outside of clinical trials. In particular, she will study the treatment patterns and risk of recurrence
among those with screen detected lung cancer compared to lung cancers diagnosed outside of
screening. These results could impact prognostic estimates, treatment choices, and future trials
to develop tailored treatment and surveillance regimens for early-stage, screen-detected lung
cancer patients and set the foundation for future studies of the natural history of lung cancer
screening in community settings. Results will be broadly disseminated through local and
national meetings as well as peer-reviewed journal manuscripts.

Public health relevance
Project Narrative Nikki Carroll, MS, supports the Cancer and Genomics Research Core at the Kaiser Permanente Colorado Institute for Health Research. Her work has made significant contributions to translational research in cancer treatment patterns and outcomes that occur in real world clinical settings (as opposed to clinical trial settings). Support from this award will allow her to continue her focus in cancer research with an emphasis on treatment and risk of recurrence in the context of screen-detected cancers.